REDUCTION OF HYPOXEMIA MORBIDITY OF INFANTS W/ PERSISTENT PULMONARY HYPERTENSION

To examine whether low levels of nitric oxide inhaled by infants with persistent pulmonary hypertension can reverse hypoxemia, thus reduce morbidity and mortality.